Clinical Immersion with Health Professionals and Industry Advising in Undergraduate Biomedical Engineering Capstone Design

This proposal is to develop a new senior year capstone design course and summer immersion program for
Bioengineering students at George Mason University. Recognizing the importance of introducing the biomedical
design process early and building on this throughout the undergraduate program, our Bioengineering
Department has introduced a new curriculum where design is taught in each of the four years. The curriculum
begins with an introductory Computer-aided design based experience in the freshmen year, followed by a
biomaterials design project in the sophomore year and a course with a product development component in
parallel with a course in clinical medicine (taught by physicians) in the junior year. The new proposed capstone
design course builds upon this foundation beginning with a summer clinical immersion program that leads into
an analysis phase of identified clinical needs in the capstone design course. To further support our design teams
in addressing patient-oriented clinical needs and emerging opportunities involving health informatics and health
policy, we will include a senior student from nursing, health informatics or health policy into each design team,
based on a skill set analysis of each project. The design teams are supported by advising teams composed of
faculty from Bioengineering, Nursing, Health Informatics and Health Policy and by industry advisors selected
from our new industry advisory board, the Mason Bioengineering Alliance. Design teams will have access to
university and medical center resources and follow an industry standard product design and development
process. Our approach includes a practical early stage assessment of clinical importance and market potential
including the important aspects of intellectual property, regulatory considerations, ethics and reimbursement.
This proposal aims to 1) establish a multidisciplinary summer clinical immersion program leading into the
Bioengineering capstone course at 3 clinical centers : Inova Fairfax Medical Campus, Children’s National
Medical Center and Georgetown University Medical Center 2) integrate Nursing, Health Informatics, and Health
Administration students and faculty into Bioengineering Design teams (students) and advisory groups (faculty)
and 3) apply in a real world clinical context our new curriculum’s foundation of multiyear design and courses in
i) Clinical Medicine and ii) Intellectual Property, Regulatory Concepts, Product Development, responding to newly
identified clinical needs. A design control approach with inclusion of relevant standards and risk analyses are
included. Workshops will teach ethics, reimbursement and oral communications. Using this integrated,
translational approach to learn design will better prepare our students to be biomedical technology innovators.
Incorporating a clinical needs finding approach and working with health professional students involved in patient
care and health administration will give our students a unique real world experience in patient-oriented
bioengineering design. With this senior design course under their belt, our students will be prepared for industry
positions, for starting their own companies, or for further graduate education.
1

Public health relevance
PROJECT NARRATIVE This proposal is to develop a new senior year capstone design course and summer immersion program for Bioengineering students at George Mason University where three neighboring clinical centers will be hosting students for summer immersion. Nursing and Health Informatics and Administration faculty and students will join Bioengineering students and faculty in this senior design program to provide a bread of skills for solving clinical challenges involving medical data and patient-oriented care. Industry advisors will be members of the advising teams to provide guidance on marketability and product development for novel solutions to newly identified clinical needs. 1